DATA AND STATISTICAL ANALYSIS FOR GLP-1 AS AN ADJUNCT TO BUPRENORPHINE. MAY 21, 2025 - FEBRUARY 29, 2028. N01DA-22-2253. TASK ORDER NO. 75N95025F00002 (TO26).

This contract supports work that is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.